The Influence of the Glucoamylase Inhibitor Acarbose on Bacteroidetes Starch Utilization and Fitness in the Human Gut

ABSTRACT
Acarbose is an FDA approved medication prescribed to type 2 diabetics and inhibits host glucoamylases,
enzymes along the upper gastrointestinal tract responsible for breaking down starch into glucose. As such, it
mitigates hyperglycemia after meals and contributes to improved glycemic control. However, acarbose shows
promise for ameliorating symptoms in a number of other diseases because of its immunomodulatory and pro-
cardiovascular effects. Despite the prospect of re-purposing acarbose to treat a variety of conditions, little is
known about how it elicits these host effects. One explanation lies in the observation that acarbose alters the
gut microbial community in mice and humans. Still, there are no published reports offering mechanistic insight
into these changes. Because less starch is digested in the upper GI tract upon acarbose treatment, it transits
to the large intestine where it is processed and fermented into short-chain fatty acids (SCFA) by commensal
bacteria. Since acarbose is minimally absorbed by the host, it likely transits with the starch to the large
intestine where it might impact bacterial glucoamylases utilized to process this polysaccharide. Recent data
suggest that common human gut colonizers exhibit remarkably different growth sensitivities to acarbose in vitro
when utilizing starch as a carbon source. A dominant and well-studied gut phylum, the Bacteroidetes, deploys
a starch utilization system, or Sus, to recognize, process, and import starch, with the prototypical system from
Bacteroides thetaiotaomicron serving as a model. Initial work for this proposal invokes disparate phenotypes
between two prominent species of Bacteroidetes: B. thetaiotaomicron is sensitive to acarbose while
Bacteroides ovatus is resistant. This proposal will determine the molecular basis for these distinct responses
and test the hypothesis that discrete molecular features of Sus contribute to differential Bacteroidetes growth
inhibition and overall fitness in the presence of ACA. Aim 1 will systematically test the possibilities that
acarbose differentially affects Sus enzyme inhibition and oligosaccharide recognition and/or transport. Aim 2
will determine how widespread acarbose sensitivity is amongst the Bacteroidetes. In vitro acarbose
phenotypes will be compared to in vivo fitness and relative abundances by mining metagenomic data-sets from
humans. The combination of approaches will test the notion that in vitro sensitivity to acarbose translates to
reduced bacterial fitness in the gut. The proposed research is timely in light of recent work suggesting that
acarbose may influence whole body signaling in mice due to microbiota mediated alterations in bile acid pools.
Recent data also suggests that acarbose may be a useful tool to control Bacteroidetes abundance in the gut, a
phylum implicated in the etiology of numerous diseases. Because acarbose positively impacts host health, a
mechanistic understanding of how acarbose influences bacterial growth in the GI tract is warranted and will lay
a foundation for the design of other xenobiotics with even stronger, or more tailored effects, than acarbose.

Public health relevance
PROJECT NARRATIVE The proposed research will determine how acarbose, a medication with numerous health benefits, impacts the growth of gut bacteria. Acarbose changes the community of bacteria in the human gut and differentially influences the ability of these bacteria to grow on starch. So, a detailed understanding of how acarbose affects bacterial starch consumption is critical as we look to use the drug to manipulate the gut microbiota towards improved health outcomes.